REasons for Geographic And Racial Differences in Stroke-Myocardial Infarction-4 (REGARDS-MI-4)

Black-White coronary heart disease (CHD) and heart failure (HF) disparities persist in the US despite decades
of research and national public health campaigns. The role of social determinants of health (SDH) like struc-
tural racism in health disparities has been studied in only 1% of published work. Few studies of SDH have
taken a life course perspective related to risk of CHD and HF. The ability to recover after the stress of an acute
health event, or resilience, is an important patient-centered outcome, but the influence of SDH on resilience is
unknown. Few past studies have examined both structural and intermediary SDH in the World Health Organi-
zation’s (WHO) Commission on SDH (WHOCSD) conceptual framework in a longitudinal national sample with
rigorously adjudicated CHD and HF endpoints, which is one of the aims of this proposal. We propose a series
of studies to fill these gaps, while also providing rigorously adjudicated CHD and HF events and causes of
death to a host of investigators interested in using these data (to date, over 500 have used these data). We
build on a track record of mentoring to propose a formal year-long career development program for early-stage
investigators (ESI), especially underrepresented minorities (URM). The specific aims of this proposal are to:
(Aim 1) conduct studies examining underlying mechanisms of health disparities, guided by the WHOCSD con-
ceptual framework, in three thematic areas: a) the incidence and recurrence of CHD; b) the incidence and re-
currence of HF with preserved ejection fraction and HF with reduced ejection fraction; c) reserve and resilience
after an incident or recurrent CHD or HF event. (Aim 2) To continue to adjudicate CHD events, HF hospitaliza-
tions, and causes of death to support a wide range of studies by investigators beyond our group, and to link the
cohort with Medicare data to support investigators conducting health services utilization studies. (Aim 3) To
support the development of researchers in CVD health equity, especially URMs, through a new mentored re-
search program for a cohort of ESIs, including analytic and statistical support and an annual 2-day Health Eq-
uity Research Summer Institute of presentations, training, mock study section, and networking. ESIs will gradu-
ate with specific competencies in CVD health equity research. The proposed grant will inform policy, advocacy,
and the design of interventions by generating new evidence on which SDH and disparities in health services
lead to population-level disparities in incident and recurrent CHD and HF, and on resilience in recovery after a
CHD or HF event. Our multidisciplinary team includes epidemiologists, sociologists, health services research-
ers, biostatisticians, clinicians, and a participant Advisory Board, assuring rigor and relevance of the proposed
research. Continued funding for the REGARDS-MI infrastructure will support a host of additional studies led by
an expanding group of investigators. Funding will also expand the cadre of researchers dedicated to discover-
ing strategies to achieve health equity for all US adults, a goal supported by NHLBI, the National Academy of
Sciences, the CDC, the American Heart Association, and all major professional societies in the US.

Public health relevance
Narrative: This proposal will study how social determinants of health, including measures of structural racism, affect coro- nary heart disease and heart failure outcomes. An interdisciplinary group of accomplished investigators will conduct studies of incident and recurrent heart disease, designed specifically to inform policies. We will provide rigorous adjudicated data and Medicare data for investigators outside our study group and provide mentorship to young investigators building careers in health equity research.